BACTERIAL GENOME RESTRICTION DIGEST ANALYSIS: FLOW CYTOMETRY DNA FRAGMENT SIZING

DNA fragment size analysis by flow cytometry has been applied to the analysis of restriction enzyme digenst of the S. aureus genome. Of the 14 fragments generated by Sma I digestion, 13 have been observed up to 360 kilobase pairs in length. This represents an extension of a factor of two of the range of fragment sizes that can be analyzed by flow cytometry. More details are contained in the Research Highlight section of this report.